Administrative Core

PROJECT SUMMARY
The Administrative Core will create and implement effective organizational processes and resources to support the proposed Center for Innovative Research, Capacity Building and Leadership Development to End Substance Use Harms (CIRCLE) P50. The Core will provide an overarching structure for high-quality, impactful research, training, and practice activities that will support the public health and educational impacts of the CIRCLE P50. This includes enacting an organizational structure to maximize collaboration and efficiencies; promoting synergies and collaborative opportunities among CIRCLE affiliates and community partners; leading as a national resource via sharing educational and scientific resources with the public, Tribal nations, and scientific communities; supporting the next generation of drug use researchers and scholars; using CIRCLE evaluation metrics to propel action and track progress; and performing strategic planning to guide next steps and future work. CIRCLE will be led by MPIs Dr. Melissa Walls and Dr. Allison Barlow with significant guidance from a Tribal Community Leadership Council, Internal Steering Committee, and External Advisory Board.